NMR STUDIES OF AGING IN CELLS, ORGANS, AND ANIMALS

NMR spectroscopy is currently being used at the NIA to study the phosphorus metabolism of peripheral muscle in BLSA subjects and other volunteers. Age-related and exercise-related effects are under investigation. Methodologic studies to further develop magnetization transfer techniques for kinetic measurements are also under active investigation.